Pathogenesis, prevention and treatment of corticosteroid-resistant gut GVHD

Project Summary: Allogeneic hematopoietic cell transplantation (Allo-HCT) can cure hematological
malignancies, but this treatment causes graft-versus-host disease (GVHD), an immune response of donor cells
against the recipient. Anti-inflammatory corticosteroid medications can often control GVHD, but in some cases,
GVHD is resistant to this treatment, especially when it affects the intestinal tract. The goal of this project is to
understand the mechanisms that cause steroid-resistant (SR) gut GVHD and to develop effective approaches to
prevent or treat SR-Gut-GVHD. Results with a newly established murine model have demonstrated that SR-Gut-
GVHD is induced by prolonged administration of corticosteroids. Corticosteroid treatment induces expansion of
IL-22-producing Th/Tc22-like cells, IL-22-dependent abnormalities in gut microorganisms, and reduced numbers
of anti-inflammatory CX3CR1hi mononuclear phagocytes (MNP) that regulate T cell expansion and control
bacterial translocation. Information from our preliminary studies and other investigators suggests that
corticosteroid treatment inhibits the polyamine-hypusine pathway in T and MNP cells and regulates the fidelity
of T cell lineage differentiation and the expansion of pro- and anti-inflammatory MNP cells. Our studies also
suggest that steroid treatment increases Ceacam-1 expression by intestinal epithelial cells, thereby increasing
bacterial transcytosis and unfavorably altering the balance between proinflammatory CX3CR1lo MNP and anti-
inflammatory CX3CR1hi MNP cells. These changes trigger a feedforward pathogenic loop consisting of
expanding IL-22-producing Th/Tc22-like cells, IL-22-dependent dysbiosis, and increased numbers of
proinflammatory CX3CR1lo MNP with decreased numbers of regulatory CX3CR1hi MNP, leading to full-blown
SR-Gut-GVHD. To test this hypothesis, this application proposes 3 aims. Aim 1 will determine whether
corticosteroid inhibition of the polyamine-hypusine pathway in T cells leads to expansion of Th/Tc22-like cells
with lineage infidelity. Aim 2 will determine whether corticosteroid inhibition of polyamine-hypusine pathway in
CX3CR1+ MNP cells augment expansion of proinflammatory CX3CR1lo MNP with reduced numbers of anti-
inflammatory CX3CR1hi MNP in response to challenge by dysbiosis. Aim 3 will determine whether observations
in murine models reflect the pathogenesis of SR-Gut-GVHD in humans and whether reversal of abnormalities in
the polyamine-hypusine pathway and whether blocking bacterial interaction with Ceacam-1 on intestinal
epithelial cells by anti-Ceacam-1 mAb prevents and reverses SR-Gut-GVHD.
Relevance: By elucidating in-depth mechanistic understanding of the pathogenesis leading to SR-Gut-GVHD in
a well characterized murine model and by assessing the relevance of the experimental results in colon tissue
from patients with SR-Gut-GVHD, results of this project could identify potentially effective approaches for
translational testing in humans.

Public health relevance
Project Narrative Allogeneic hematopoietic cell transplantation (Allo‐HCT) is a curative therapy for hematological malignancies, but graft versus host disease (GVHD), particularly corticosteroid resistant gut GVHD (SR‐Gut‐GVHD), remains the major obstacle, because the mortality of SR‐Gut‐GVHD is 70‐90%. The proposed studies will unravel the pathogenesis of SR‐Gut‐GVHD and develop new approaches for preventing and treating the disease.